Elucidating the Molecular Mechanisms of Conformational Switching during Protein Insertion into Membranes

Conformational switching associated with the conversion of a protein structure from a water-soluble to a
membrane-inserted form is a critical step in several cellular processes; our ability to predict and manipulate such
switching can be beneficial to human health. Notable examples of conformational switching include tumor
targeting by the pH Low Insertion Peptide (pHLIP), cellular entry of bacterial toxins, and membrane-induced
activation of the Bcl-2 family of apoptotic regulators. While these processes are of fundamental biomedical
importance, the mechanism of conformational switching needs to be better understood. Specifically, the role of
lipid composition and divalent cations in modulating membrane insertion remains largely unexplored, despite the
mounting evidence of their physiological importance. We will test our hypothesis that changes in lipid
composition, Ca2+ and Mg2+ concentrations, and pH play key roles in modulating conformational switching on
membrane interfaces. In Aim 1, we will decipher the thermodynamic rules for predicting protein-membrane
interactions by characterizing the protonation- and Ca2+/Mg2+-dependent bilayer partitioning of model peptides.
We will use our findings to advance the existing tools for sequence-based predictions of membrane interactions
and make them readily applicable to more realistic descriptions of the complex cellular environment. Specifically,
we strive to predict the effects of divalent cations and the changes in pKas of titratable amino acid residues on
membrane interfaces, which are critical for understanding membrane-dependent conformational rearrangements
that underlie the functioning of many systems of biomedical importance. In Aim 2, we will determine the role of
lipid composition in modulating the pH-dependent and Ca2+/Mg2+-dependent folding and transmembrane
insertion of pHLIP. This will include (a) deciphering the coupled effect of Ca2+/Mg2+ and lipid composition on
pHLIP targeting to model membranes, (b) determining the conformation of pHLIP-lipid complexes by molecular
dynamics (MD) simulations and spectroscopic experiments, (c) establish the role of individual acidic residues in
the conformational switching of pHLIP and (d) determining the protonation of anionic residues in membrane-
inserted pHLIP by NMR spectroscopy. In Aim 3, we will test whether the molecular determinants identified in
Aim 2 are sufficient to describe the behaviors of pHLIP in complex lipid systems containing de-mixed liquid
domains, and in mammalian cells (i.e., we will determine the effect of pH, divalent cations, PS, and cholesterol
on the interaction of pHLIP with cellular membranes).

Public health relevance
PROJECT NARRATIVE The proposed work seeks to understand the mechanism of protein conformational switching on membrane interfaces, a fundamental and unanswered question in cell biology that is crucial for proper cellular functions and of major relevance to cancer therapy. Using a battery of complementary experimental and computational approaches, we aim to characterize the interplay of lipid properties, pH, and divalent cations in modulating the tumor-targeting action of the pH Low Insertion Peptide (pHLIP). We will also refine and advance sequence-based prediction of protein-membrane interactions. The results of the proposed studies will be instrumental in the development of molecular platforms for cell-selective targeting and to advance therapeutic strategies.